Identifying targetable apoptotic vulnerabilities for the treatment of AL amyloidosis

ABSTRACT
Immunoglobulin light chain (AL) amyloidosis is a highly lethal disorder characterized by the production and
deposition of fibrillogenic immunoglobulin light chains in vital organs. These misfolded light chains are
produced by a clonal population of diseased plasma cells, which are therapeutically targeted with the use of
proteasome inhibitors and immunomodulatory agents. However, these treatment regimens were developed for
the more common plasma cell disease multiple myeloma and have only limited efficacy in AL amyloidosis as
demonstrated by the 2-3 year median survival for patients that do not receive an autologous stem cell
transplant. Improved therapies for patients diagnosed with AL amyloidosis are therefore urgently needed,
especially well-tolerated treatments that are able to facilitate long-term remissions. We have previously
discovered that the state of the apoptosis pathway in cells, both in vitro and in the clinic, profoundly alters their
chemosensitivity and clinical outcomes. In addition, a preponderance of evidence demonstrates that
upregulation of pro-survival proteins from the BCL-2 family including BCL-2, BCL-XL and MCL-1 can be major
drivers of therapy resistance across multiple cancer types, highlighting the importance of this pathway in
governing responses to chemotherapy. The recent development of novel small-molecule inhibitors of the major
pro-survival proteins from the BCL-2 family has created an unprecedented opportunity to target apoptotic
dependencies in cancer cells, a strategy that may be particularly effective in the dysfunctional clonal plasma
cells that drive AL amyloidosis. However, the landscape of apoptotic dependencies in AL amyloidosis and how
they may be exploited to improve patient responses is not known. Using primary bone marrow-derived clonal
plasma cells from both treatment-naïve and treated AL amyloidosis patients, we have recently discovered that
clonal plasma cells exhibit strong dependencies on BCL-2 family proteins, which change dramatically in
response to treatment with existing front-line therapies. Our central hypothesis is that BH3 mimetics will be
highly effective agents for the treatment of clonal plasma cells in patients with AL amyloidosis, both as single
agents and in combination with front-line therapies. To test this hypothesis, we will 1) identify apoptotic
dependencies in clonal plasma cells from AL amyloidosis patients at baseline and during treatment with front-
line and experimental therapies; 2) investigate molecular mechanisms regulating apoptotic dependencies in AL
amyloidosis clonal plasma cells and how they may be used as clinical biomarkers; and 3) develop mouse PDX
models of AL amyloidosis to study disease development and progression as well as BH3 mimetic efficacy and
toxicity. This study addresses the important problem of limited therapeutic options for patients diagnosed with
AL amyloidosis by identifying highly-efficacious therapeutic approaches utilizing BH3 mimetics in this disease.
If successful, we expect to meaningfully improve patient outcomes and be a step closer to eventual cures.

Public health relevance
NARRATIVE AL amyloidosis is an invariably lethal disorder characterized by the production and deposition of abnormally folded immunoglobulin light chains in vital organs by diseased plasma cells. We will use innovative research tools and analyses to develop improved, combination-based therapies for AL amyloidosis that will prevent the emergence of therapy resistance and move us closer to eventual cures.